Managing Health Disparities/Advantages in a Racially-Ambiguous Population: Beyond OMB Race/Ethnic Categories for Population Health

Abstract: Our objective is to host a two day in-person conference in 2018, in which Consensus panels in this conference will identify research areas and research questions in the following areas: limitations of the US Binary Racial narrative to identify and track health disparities in an increasingly racially ambiguous population; predictive limits of Social Determinants of Health as proxy measures for Race/Ethnicity (R/E) in a racially ambiguous population; and the use of the Latin American Multivalent Racial narrative in researching health disparities in a racially ambiguous population.

Public health relevance
Narrative: This working conference will examine the limits of the US Binary Racial system categorization system to identify and track health disparities in a population with a large, racially ambiguous population, and will discuss the limits of utilizing Social Determinants of Health as proxy measures for Race/Ethnicity. Various perspectives will focus on the California 2010 birth cohort (41% racially ambiguous) as a starting point on its implications for researchers, hospital administrators responsible for Population Health initiatives, parents of racially ambiguous children, and the lived experiences of racially ambiguous adults. The Latin American Multivalent Racial perspective will be discussed for possible ideas to conduct disparities research in racially ambiguous populations.